2025 Eye Movements Gordon Research Conference and Gordon Research Seminar

Project Abstract
This proposal requests partial support for Eye Movements: Understanding Perception, Cognition, and Action in
Health and Disease, a unique international meeting on eye movements – their underlying mechanisms,
associated disorders, and possible treatments and applications – that is part of the Gordon Research
Conference (GRC) series, to be held July 6-11, 2025 at Mount Holyoke College in South Hadley,
Massachusetts. It is preceded by a Gordon Research Seminar (GRS) organized and hosted by and for
trainees to be held July 5-6 2025. The long-term goal of the Eye Movement Gordon Conference is to increase
our understanding of eye movements to advance our basic science knowledge and to improve our ability to
diagnose and treat disorders of ocular motility, gaze control, and vision, and additionally to understand how
eye movement abnormalities can be used to diagnose underlying brain disease and injury. To accomplish this
goal, we have put together a program that reflects the diverse expertise and research areas that include the
remarkably broad intellectual landscape of our field. We will assemble 38 invited speakers and discussants
that span the full range of scientists – from trainees to senior investigators whose research spans the full
breadth of our field – from the molecular level to whole system behavior. We anticipate approximately 140
participants for the five-day meeting in a secluded and inclusive setting. The program will have 9 sessions on a
wide range of topics including: infantile nystagmus; control of fixational eye movements; understanding how
individual differences alter eye movements; eye movements during reading and during decision-making; how
new cutting edge approaches are opening up new understanding of how eye movements are controlled by the
brain; how vestibular implants can alter eye movement abnormalities; and finally how eye movements can be
used as biomarkers to diagnose central nervous system dysfunction. Four poster sessions will facilitate
scientific exchange and mentoring among all participants. “Power Hour: Committed to Inclusion and the
Professional Development of Women and Underrepresented Minorities in Science” will provide an opportunity
to support the professional growth of women and under-represented minorities, and is open to all attendees,
and will focus on building inclusive laboratory and research practices. From the associated GRS, we will draw
speakers for the morning sessions to give short talks to provide an opportunity for trainees to present to the
entire conference. In size and intensity, the Eye Movements Gordon Research Conference is significant in our
field for its ability to disseminate the latest unpublished scientific advances, foster productive new insights and
collaborations, stimulate interest in eye movement research among young investigators, and increase the
diversity of the research workforce, all with the ultimate goal of accelerating the discovery of desperately
needed new therapies for people with disorders of ocular motility, gaze control, and visual function.

Public health relevance
Project Narrative Understanding eye movements and how they control vision, as well as developing improved treatments for disorders that affect them, are core missions of the National Eye Institute. The Eye Movements Gordon Research Conference and Seminar will assemble early-, mid- and late-career scientists and trainees in a relaxed and inclusive atmosphere that will maximize interactions between all participants, allow for the development of new directions, and increase research collaborations toward developing solutions for eye movement disorders. Sessions will focus on understanding how the brain controls eye movements, individual differences at the behavioral and molecular levels, and what goes awry with injury or disease.